ShEEP Request for MESO SECTOR S 600MM Ultra-Sensitive Plate Imager

Project Summary
The MESO SECTOR S 600MM Ultra-Sensitive Plate Imager (with Methodical Mind software) is the flagship
instrument of MSD. Its high-speed, low noise CCD camera provides high sensitivity, wide dynamic range, and
rapid read times. This instrument equipped with 96 well and 364 well capacity delivers the industrial-grade
throughput and reliability required in the most demanding research environments. This instrument can be used
for the following applications: (i) metabolic research, (ii) immunology/inflammation research, (iii) bone disorders,
(iv) cardiovascular diseases, (v) neurobiology/neurodegeneration research, and toxicology studies that are
associated with cardiac injury, kidney injury, and liver injury. Cytokines and chemokines are small signaling
proteins secreted primarily by immune cells. Their main function is to coordinate cell growth, proliferation, and
differentiation. Cytokines and their receptors participate in a diverse array of functions including innate and
adaptive immunity, inflammation, immune cell differentiation, angiogenesis, tumorigenesis, development,
neurobiology, and viral pathogenesis. Dysregulation of cytokine expression is a cause of immunological and
inflammatory diseases, as well as other disease conditions. Many different cell types secrete chemokines, most
often to attract immune cells to the site of infection or injury during innate and adaptive immune responses.
The capability to measure cytokines/chemokines in small tissue or plasma samples will significantly and
positively impact many VA-sponsored projects in basic, translational, and preclinical biomedical/behavioral
research relevant to Veteran’s healthcare currently conducted at the VA San Diego Healthcare System
(VASDHS). Cytokines/chemokines are affected in several disease states including hypertension, diabetes,
obesity, cancer, osteoarthritis, addiction, traumatic disorders, bipolar disorders, inflammatory bowel diseases,
alcohol abuse, and chronic kidney diseases. We are a group of 10 currently VA funded and 5 previously VA
funded investigators with VA Merit and CDA Awards who will directly benefit from acquisition of VASDHS does
not have the MESO SECTOR S 600MM Ultra-Sensitive Plate Imager. Our projects encompass a wide range
of fields and research, including nephrology/hypertension, endocrinology, neurology, anesthesiology,
pulmonary and critical care, gastroenterology, rheumatology, immunology, cardiology, urology, and psychiatry.
The acquisition of the VASDHS does not have the MESO SECTOR S 600MM Ultra-Sensitive Plate Imager will
not only impact basic pre-clinical research at VASDHS, but also is expected to have a strong and positive effect
through improvement of patient clinical care and supporting the VA healthcare mission.

Public health relevance
Project Narrative Besides clinical samples, small animals (mice and rats) are vital pre-clinical models in VA San Diego Healthcare System (VASDHS) research community, and they enable the fundamental and translational investigation of mechanisms underlying an increasingly complex set of diseases and injuries that impact Veterans and their caregivers. Several inflammatory and anti-inflammatory compounds called cytokines/chemokines are altered in obesity, diabetes, cancer, osteoarthritis, intestinal bowel disease, chronic kidney disease, and bipolar disorder. The MESO SECTOR S 600MM Ultra-Sensitive Plate Imager is designed to measure the above compounds in small tissue or plasma samples. Therefore, the acquisition of the ultra-sensitive plate image system significantly and positively impact a large number of VA-sponsored projects in basic, translational and preclinical biomedical/behavioral research relevant to Veteran’s healthcare currently conducted at the VASDHS.